Biology of the Lung: A Multidisciplinary Program

“Biology of the Lung: A Multi-Disciplinary Approach” has been the title and theme of this T32 since it
began in 1975. For years 46-50, we propose to train 6 predoctoral PhD candidates and 6 postdoctoral fellows
(3 PhD and 3 MD) per year in lung biology research, in the only T32 providing lung science training at Boston
University. Our overarching goals are: 1) To train the next generation of PhD and MD scientists in 3 scientific
foci (SFGs) that are special strengths at BU: lung Development & Regenerative Medicine, lung Infection &
Immunity, and lung Biomedical Data Sciences; 2) To use multidisciplinary approaches (including these SFGs)
to enhance the training environment, enrich the learning experiences of trainees, and better prepare our
graduates for careers in lung science; and 3) To imbue in our trainees, in particular women and those from
under-represented groups (URGs), the importance and excitement of discovery and creation of new
knowledge that will improve the lung health of all populations, especially the at-risk populations we serve,
through didactic and highly interactive courses and seminars. These 3 goals encompass all of the 6 NHLBI
strategic trainings guidelines. We will provide exemplary training by exceptional faculty mentors from 7
departments across 3 schools in order to establish expertise in 11 discipline-specific core competencies that
we have designed in lung biology broadly, and specifically in the areas of regenerative and reparative
medicine, “omics”/computational biology, immunology/infectious diseases, and population studies including
comparative effectiveness and outcomes research. The Boston University environment is ideal for recruiting,
advancing, and retaining URG trainees from diverse backgrounds, as evidenced by its 145 year history of
training URG scholars and our successful T32 track record. Our T32 faculty have designed unique trainings in
the responsible conduct of research and created new programs for recruitment and retention of scientists from
URGs that have been adopted school-wide. The keystone principle of our training program is bi-directional
translation of ideas between basic and clinical spheres. This is why we train MD fellows together with PhD
post-doctoral fellows, MD/PhD students, and PhD students in a unified program which includes a unique
weekly Combined Clinical and Research (CCR) conference where all our basic researchers, physician
scientists, educators, and clinicians interact. Our current program plan represents the very best we have
offered in over 45 years of training exceptional lung researchers and international pulmonary medicine
thought-leaders, including numerous Deans, Department or Division Chairs, Center Directors, and Industry
leaders, on track to produce the next generation of trail-blazers in multidisciplinary lung science.

Public health relevance
Project Narrative The science of health and disease has become increasingly complex, requiring highly coordinated research efforts to ask and answer relevant questions and sophisticated environments to train the individuals who will make tomorrow's most important discoveries. This T32 program offers training for predoctoral PhD students and postdoctoral MD and PhD fellows in the most advanced areas of lung science in an integrated fashion, concentrating on providing high quality mentorship in the scientific disciplines most likely to make advancements in the diagnosis and treatment of lung diseases: Immunology & Infection, Development & Regenerative Medicine, and Biomedical Data Sciences.